Monofunctional 3 to 10 nm Covalent Gold Labels for CryoEM

DESCRIPTION (provided by applicant): Gold nanoparticles are the label of choice for electron microscopy (EM) since they offer a choice of sizes that provide quantitative, high-resolution identification of targets. Recently, high-resolution EM methods including cryoEM and electron tomography have benefitted from significant advances in instrumentation and a series of breakthroughs in specimen processing and preparative equipment that have made these methods widely accessible. However, conventional colloidal gold labels do not allow the full realization of the potential in these methods, because they require extensive stabilization with large macromolecules that limit penetration and antigen access, and also because their mechanism of conjugation, through adsorption to targeting antibodies or proteins, does not allow direct labeling of specific reactive sites within macromolecular complexes at sufficiently high resolution. Nanoprobes has developed 1.4 nm (Nanogold) and 0.8 nm (Undecagold) gold nanoparticle labels with a single reactive group for selective, covalent labeling of thiols (cysteie residues), amines (N-terminal amines or lysine residues), or other functional groups. However, these are too small to be readily visualized in many types of specimens, and do not allow multiple labeling. Although covalent reactivity has been introduced into larger particles, preparing monofunctional reagents capable of 1: 1 labeling has proved highly challenging. To date, no products are available with native monofunctional reactivity. We will synthesize gold nanoparticles that combine a high degree of monodispersity, controlled surface functionalization and selective reactivity with monofunctional reaction stoichiometry. Preparations will be scaled and simplified to deliver nanoparticles with the following properties in an efficient, reproducible and economical manner on any scale: (1) Monodispersity: populations of gold nanoparticles from 3 nm to 10 nm will be prepared with coefficients of variation of 10% or less using thiocyanate reduction, citrate/tannic acid, or homogeneous reduction. (2) Surface properties: A universal base set of organic ligands will be developed that can confer (a) water-solubility and biocompatibility, (b) desired degree of hydrophobicity, (c) specific covalent reactivity, and (d) controlled shell thickness from 0.6 nm to 3 nm. Enable selection of any combination of these properties for any size. (3) Specific reactivity: amine, thiol, and activated carboxyl reactivity ill be introduced by (a) incorporation of a primary amine during synthesis and later modification, and (b) insertion of protected reactivity then deprotection. (4) Monofunctionality: four strategie will be used to generate particles that react with a single conjugate molecule in solution: (a) isolation from statistical mixture; (b) immobilization using a cleavable cross-linker that generate a unique group upon cleavage; or (c) conjugation of one or very few larger protein tags using cleavable cross- linkers, separation of gold particles by numbers of tags and cleavage to yield precisely functionalized gold particles; and (d) polymeric ligands bridging multifunctional gold coordination with a single cross-linking group. Monofunctionality will be tested in collaboration with Alasdair Steven (NIAMS, NIH) using cryoelectron microscopic labeling and electron tomographic experiments of multi-functional proteins in which site-specific labeling without aggregation will be used to confirm truly monofunctional reactivity. Monofunctional gold nanoparticles would also provide innovation to address a critical challenge in nanoscience: enabling the construction of molecular nanodevices in which multiple nanoparticles with unique and different properties and attachment points perform a coordinated set of actions to complete a task. Construction of such a system requires the assembly of particles with different properties into a construct by attachment at different sites. As a key enabling technology for this, monofunctional gold nanoparticles will help afford a new generation of nanotechnology innovations such as biosensors, indicators, and molecular devices that perform targeted, programmed tasks such as oligonucleotide annealing, temperature sensing, or selectively delivering medication or enhanced local radiation dose to tumor cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed work will provide new labels for labeling macromolecular protein complexes, organelles, and tissues at high resolution for study by cryoelectron microscopy, electron tomography or other high-resolution electron microscopic methods. These will allow researchers to identify and locate proteins and other molecules that play critical roles in biological and disease processes at a higher level of resolution than is currently possible. This will enable new insights into the mechanisms of these processes at the molecular level, providing researchers with opportunities to develop new approaches to the diagnosis and therapy of disease, developmental disorders, and other health conditions, resulting in earlier diagnosis and safer, more effective therapies. In addition, gold nanoparticle possess a wide range of useful optical, electronic and visualization properties which make them ideal for a wide variety of nanotechnology applications as biosensors, indicators, or even nanoscale devices that can initiate useful events at or within targets to which they have been delivered, such as oligonucleotide annealing, temperature sensing, or selectively delivering an enhanced local radiation dose to tumor cells. Monofunctional gold nanoparticles will provide a key technology to address an important current challenge in nanoscience: to move from the applications of single, isolated nanoparticles, to the construction of extended arrays in which multiple nanoparticles with unique and different properties and attachment points perform a concerted set of actions that completes a more complex task. Construction of such a system requires the assembly of particles of multiple sizes and perhaps varying properties into a construct in which each one is attached at a different site via a different chemical reaction. The proposed work will provide the means to accomplish this and will therefore help enable a new generation of nanotechnology innovations to address a variety of critical public health problems such as cancer and Alzheimer's Disease.